IGF::CT::IGF THE PURPOSE OF THIS CONTRACT IS TO PERFORM PROSPECTIVE FOLLOW-UPS, INCLUDING ADJUDICATED DIAGNOSTIC ASSESSMENTS AND COGNITIVE EVALUATIONS, OF OLDER WOMEN IN THE WHIMS STUDIES, TO PROVIDE

IGF::CT::IGF THE PURPOSE OF THIS CONTRACT IS TO PERFORM PROSPECTIVE FOLLOW-UPS, INCLUDING ADJUDICATED DIAGNOSTIC ASSESSMENTS AND COGNITIVE EVALUATIONS, OF OLDER WOMEN IN THE WHIMS STUDIES, TO PROVIDE